The 2nd International "T Cells in the Brain (TCB2025): Decoding T Cell Targets in Neurodegeneration"

Project Summary
T cells play a pivotal role in various neurological disorders, and their involvement is a critical aspect of the
immune response within the central nervous system. Despite the significance of T cells in neuroinflammation
and neurodegenerative processes, the identification of T cell targets in these contexts remain challenging. In
recent years, advancements in basic and clinical neuroimmunology have improved our comprehension of T
cell pathophysiology in neurological disorders. However, research efforts often exist in isolation, lacking a
unified platform for meaningful collaboration between basic immunologists, neuropathologists, T cell
engineers, computational biologists and clinicians. To address this gap, “T Cells in the Brain 2025
(TCB2025): Decoding T Cell Targets in Neurodegenerative Diseases” aims to consolidate recent
scientific progress and integrative approaches towards T cell-related therapy. This conference will bring
together experts in the field to share cutting-edge insights and foster interdisciplinary discussions that can
catalyze the development of therapeutic interventions targeting T cells in neurodegenerative diseases.
Recognizing the importance of diversity in scientific research, TCB is committed to enhancing inclusivity by
actively encouraging the participation of young investigators, women, and underrepresented minority (URM)
researchers. By providing a platform for collaborative discourse, TCB aspires to accelerate the development
of effective T cell-based therapies for neurodegenerative disorders.

Public health relevance
Project Narrative The Second conference entitled “T Cells in the Brain 2025 (TCB2025): Decoding T Cell Targets in Neurodegenerative Diseases,” will assemble an international roster of scientific investigators to address the multi-disciplinary nature of neuroinflammation research in neurodegenerative diseases, better define the specificity of T cells, facilitate robust immunotherapy trials in neurodegenerative diseases, help establish future leaders in neurodegenerative research, and to promote diversity in the field.